Implementation research to improve the uptake of influenza vaccination in CKD

ABSTRACT/ PROJECT SUMMARY
Dr. Junichi Ishigami, MD, MPH seeks a Mentored Research Scientist Development Award in order to obtain
essential skills and mentored research experience to become an independent investigator in the field of
implementation research to improve the uptake of influenza vaccination among individuals with chronic kidney
disease (CKD). The research proposal details a five-year plan consisting of implementation research to
improve the uptake of influenza vaccination among individuals with CKD, and advanced coursework at the
Johns Hopkins Bloomberg School of Public Health under the combined mentorship of Dr. Kunihiro Matsushita,
MD, PhD, and Dr. David Dowdy, MD, PhD. Influenza affects 10-35 million individuals annually in the US,
resulting in up to 710,000 hospitalizations and 56,000 deaths. Vaccination against influenza is especially
important for individuals with CKD due to their high risk of influenza complications (e.g., pneumonia,
cardiovascular disease). Yet, we have recently reported that ~40% of adults aged ≥65 years with non-dialysis
dependent CKD in the US did not get an influenza vaccine and the vaccination rate has not improved between
2005 and 2015. This indicates that additional efforts are urgently needed to improve the uptake of influenza
vaccination particularly in this high risk population. However, no evidence-based implementation strategies
exist to improve the uptake of influenza vaccination specifically among individuals with CKD. The proposed
project will address this public health concern. The specific aims of this research proposal are 1) To determine
patient and provider perceptions about influenza vaccination in nephrology care, 2) To design a theory-based
vaccination program and test its feasibility in nephrology care, and 3) To evaluate the cost-effectiveness of a
theory-based vaccination program in nephrology care. To address these issues, we will leverage the Chronic
Renal Insufficiency Cohort (CRIC), an NIDDK-funded, ethnically-diverse, well-documented, contemporary,
longitudinal cohort of 5,499 persons aged 21-74 years at baseline with a variety of CKD stages. This project
will inform implementation strategies to enhance an effective influenza vaccine delivery in CKD, provide proof
of concept of promoting influenza vaccination in nephrology care, and provide information on the cost-
effectiveness of a theory-based vaccination program for decision-making on resource utilization. Together, this
project will pave a theoretical foundation for developing cost-effective and feasible vaccination programs for
individuals with CKD, which can be further extended under other funding mechanisms such as an R01. This
project will make the candidate fully equipped to be an independent investigator and also will provide an
evidence base for improving influenza vaccine uptake in CKD, an understudied and important clinical priority in
nephrology care.

Public health relevance
NARRATIVE/RELEVANCE Individuals with CKD are most in need of vaccine protection, yet their uptake of influenza vaccination is suboptimal. Through this project, the candidate will establish effective strategies to improve the uptake of influenza vaccination among individuals with CKD, and obtain necessary skill sets and experiences to make a successful transition to an independent researcher.